Centromere Identity and Function

Project Summary/Abstract Defects in the equal partitioning of chromosomes at cell division causes aneuploidy, a genetic catastrophe that results in spontaneous abortion or birth defects if it arises in the gametes and that is a major contributor to gene dosage imbalances in almost all human cancers. The centromere is the locus on each chromosome that directs accurate chromosome segregation at cell division in healthy cells. The focus of this project is to address three related major questions regarding centromeres: How are centromeres established? How are centromeres maintained over the long timescale that human biology requires? What is the relationship between the epigenetic components that define centromere location and the DNA sequences that rapidly evolve at mammalian centromeres to drive chromosome evolution? Centromeres are the chromosomal loci that confer genetic stability at cell division, but the DNA sequences typically found at the loci are paradoxically neither necessary nor sufficient for centromere function. Rather, centromeres are specified in metazoans and many other eukaryotes through an epigenetic process. Key to epigenetic centromere specification is a histone H3 variant, CENP-A, and in this proposal we now build on the major findings we made in the previous funding cycle regarding a nucleosome structural transition conferred by its close binding partner, CENP-C, the regulation of its cell cycle-coupled chromatin assembly, its role in the earliest steps in centromere formation, and defining the major oligomeric form and structural “signature” of CENP-A nucleosomes at human centromeres. We have identified three critical areas of investigation that are now ripe for eliciting major insight at centromeres: 1) the molecular basis for how centromeres are epigenetically maintained, 2) the processes that are coupled to the genesis of a new centromere, and 3) the molecular underpinnings of centromere changes implicated in chromosome evolution. We will pursue these topics using biochemical, genomic, structural, molecular genetic, and cell biological approaches, and together these studies have the promise to generate valuable insight into the epigenetic and genetic features of the centromere that ultimately ensure stable inheritance of the genome at cell division.

Public health relevance
Project Narrative Chromosomal inheritance must be flawless every time the cell divides or else unequal chromosome partitioning in the daughter cells, along with the imbalanced dosage of the genes that they carry, will lead to major medical problems such as spontaneous abortion of embryos and fetuses, birth defects in newborns, and tumor formation and progression in adults. Genome partitioning is controlled by proteins that usually reside on highly repetitive DNA at a single locus on each chromosome. The work proposed here promises to advance our knowledge of how this critical process is performed without error in healthy cells and which molecules may be to blame when catastrophic loss or gain of a chromosome occurs in disease.